Mechanisms of tubular lysosome induction in animal health and longevity

Abstract
Quality control machinery helps cells to remove damage and maintain optimal functionality. The autophagy-
lysosome system is one critical component of the cellular quality control machinery. During autophagy, cargo is
delivered via autophagosomes or other mediators to the acidic lysosome compartment, where pH-sensitive
hydrolases digest the cargo and thereby recycle molecular “building blocks” and nutrients. Notably, autophagy-
lysosome dysfunction is a conserved hallmark of aging; with age, autophagic activity declines, leading to a build-
up of damage that contributes to degenerative disease. Identifying ways to boost lysosome function could reveal
effective strategies to enhance animal health, particularly in older ages. Traditionally, lysosomes are depicted as
vesicular organelles, and variation in lysosome activity is most attributed to differences in acidity. However, we
have recently uncovered an alternative mechanism by which lysosome proficiency can be amplified: under high
autophagic demands (such as during starvation or other stress), lysosomes dramatically alter their form,
changing from vesicles to expansive, interconnected, tubular networks that show heightened degradative
capacity. Importantly, preventing formation of tubular lysosomes (TLs) reduces autophagic turnover and negates
the pro-longevity effects of food limitation, a longevity paradigm requiring high autophagic activity. In contrast,
we have found that experimentally stimulating TL induction by genetic means improves animal health during
aging and suppresses age-related disease phenotypes. By our model, lysosomes become rate-limiting in the
autophagy process when they cannot transform into expanded tubular structures, and lysosome expansion into
TLs establishes a larger, dynamic platform for search and capture of cargo, which becomes important under
high autophagic demands and supports longevity under such conditions.
In this study, we will apply our expertise in two invertebrate model organisms (C. elegans and Drosophila) to
further investigate mechanisms of TL formation and their implications for healthy aging and prevention of age-
dependent degenerative diseases. In Aim 1, we will survey the requirement of TLs in different longevity
paradigms and test the ability of TLs to minimize gaps between healthspan and lifespan. In Aim 2, we will
evaluate how new candidate TL regulators that control phosphoinositide biosynthesis, ATP transport, and
lysosome-membrane dynamics contribute to TL activities in healthy aging. In Aim 3, we will test if TL induction
can be applied to improve health and physiology in animal models of human degenerative diseases. These
studies have the potential to redefine our picture of the cell while also pointing the way to healthier lifespans.

Public health relevance
Project narrative Lysosomes are digestive organelles in the cell that degrade molecular waste and other cargo via autophagy, and their dysfunction leads to a collapse in cellular homeostasis that contributes to various age-associated disorders. While lysosomes have traditionally been viewed as morphologically static compartments, we have found that lysosomes in fact possess a remarkable morphological versatility, transforming from vesicles into expanded, interconnected, tubular networks when the demand for autophagy is high. The proposed studies aim to investigate mechanisms by which tubular lysosome networks form and how they may be harnessed to promote animal health and longevity, with the goal of clarifying new aspects of cell biology that have significant implications for animal physiology and age-related diseases.